Modulation of epigenetic programming of tissue resident macrophage lineages to impact HIV-1 infection, maintenance, and persistence.

Project Summary / Abstract
It is only recently that the field became aware that certain tissue resident macrophages, including alveolar
macrophages and microglial cells, are fetal stem cell derived lineages that behave markedly differently from
blood monocyte derived macrophages. With such knowledge we need revisit the role of tissue resident
macrophages as HIV-1 reservoirs and their contribution to viral persistence. We have shown that regulatory
pathways in infected macrophages, such as pro-survival pathways, can be inhibited by targeting specific
lncRNAs, thus driving selective cell death in infected but not uninfected macrophages. Such observations lay
the groundwork for eradication of HIV-1 reservoirs, however, biologics, such as lncRNAs, are not as tractable as
small molecule inhibitors to progress into therapeutics.
We have extensive, documented expertise in macrophage biology in both mouse and human lung, and
we have maintained a productive anti-TB drug discovery program based on phenotypic screening for compounds
active in infected macrophages. With this expertise we propose the identification and functional characterization
of small molecule epigenetic inhibitors capable of modifying host macrophage programming to drive selective
induction of cell death in specific myeloid cell lineages, and probing the underlying mechanism(s).
Our Specific Aims are:
1. Phenotypic Profiling HIV-1 infected HMDMs and AMs by transcriptional analysis. We will conduct
transcriptional profiling on HIV-1 infected HMDMs and AMs to assess the diversity of the cellular
responses to infection in both active and latent infection states in the two lineages.
2. Screening small molecule inhibitors of epigenetic programming in experimental infection in
HMDMs and AMs, and in HC69.5 microglial cells. We have a library of 735 small molecule epigenetic
inhibitors and will screen this compound collection against HIV-1 infected HMDMs, AMs, and against the
immortalized human microglial cell line HC69.5, with the emphasis on identifying compounds that drive
cell death across the different macrophage lineages and infection models.
3. Progressing hits through mode-of-action studies to identify actionable compounds. We propose
analysis of HIV-1/macrophage biology prioritizing compounds that induce cell death in HIV-1 infected
macrophages. Finally, to evaluate candidate compounds for their ability to drive cell death and suppress
viral persistence we will assess activity through ex vivo drug treatment and cell survival and viral
outgrowth from AMs from viremic HIV-1 positive human donors in Malawi.

Public health relevance
Project Narrative Tissue resident macrophages are thought to play an important role in viral persistent because of their ability to survive HIV-1 infection, but have been understudied because of their paucity and inaccessibility. We propose addressing this shortfall through screening a small molecule library of epigenetic inhibitors to identify those pathways leading to selective cell death in a range of myeloid host cell lineages including HMDMs, alveolar macrophages, and microglial cells. Compounds identified as active will be assayed directly against HIV-1 positive patients’ cells, and characterized for the mode of action to identify novel therapeutic approaches towards HIV-1 reservoir eradication.